Physics-based characterization of functionally relevant protein conformational dynamics

PROJECT SUMMARY
With recent advances in structural biology and supercomputing technology, all-atom molecular dynamics
(MD) simulation technique has gained momentum as a prominent tool for the study of protein structural
dynamics. Brute-force MD, however, is not capable of adequately sampling most functionally relevant
biomolecular processes such as large-scale protein conformational changes. Various approaches have been
developed over the last three decades to address the “timescale gap” that hinders the use of MD in real-
world applications. Free energy calculation methods, enhanced sampling techniques, and path-finding
algorithms are examples of umbrella terms that describe many of these methods. This project specifically
aims at employing, tailoring, and fine-tuning state-of-the-art enhanced sampling and path-finding
algorithms to address important biological and biomedical questions. The overall aim of this project is to
develop and employ robust and practical sampling and analysis protocols to study functionally relevant
conformational changes of various proteins from fibroblast growth factor to coronavirus spike protein. Our
proposed methodological framework specifically takes advantage of (1) robust theoretical formalisms
rooted in nonequilibrium statistical mechanics and differential geometry; (2) system-specific enhanced
sampling protocols that are tunable for the specific problem at hand; and (3) and integrative and synergistic
approach to experimental (specifically smFRET) and computational (specifically MD) techniques. Some
of the systems proposed to be studied here include proton-coupled oligopeptide transporters, influenza
hemagglutinin, ATP-binding transporters, coronavirus spike proteins, mechanosensitive channel of large
conductance, membrane insertase YidC, serotonin transporter, and fibroblast growth factor (FGF) protein.
The common theme in all of these projects is the large-scale conformational changes involved in the
function of these proteins. The successful use of the methodology proposed in this project will allow the
characterization of these conformational changes at the molecular level and pave the groundwork for the
routine application of state-of-the-art enhanced sampling techniques in the study of real world biological
problems.

Public health relevance
PROJECT NARRATIVE Large-scale protein conformational changes play a crucial role in the function of proteins; however, these processes are not well-understood at the molecular level. This project aims at bridging the gap between the computational methods and real-world biological problems by developing and employing enhanced sampling molecular dynamics simulations to study proteins from human fibroblast growth factor to coronavirus spike protein.